Diversity Supplement Pennington

PROJECT SUMMARY/ABSTRACT
Please see Research and Career Plan.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Stroke in the newborn period is a common cause of long-term neurodevelopmental dysfunction, with profound socioeconomic impact, and diagnosis is frequently delayed. The overall goals of this proposal are to better understand how the developing brain responds to early injury, and to identify novel therapeutic strategies to increase repair and improve outcomes even when treatment is delayed.